Novel Anticonvulsants for Nerve Agents and Refractory Status Epilepticus

Project Summary
The overall goal of this proposal is to develop novel hydrophilic neurosteroids as anticonvulsants to control
midazolam-refractory seizures and brain damage caused by nerve agent exposure. Acute exposure to nerve agents
or organophosphate (OP) intoxication can result in refractory status epilepticus (RSE), and permanent brain damage
or death. Benzodiazepine anticonvulsants (diazepam and midazolam) have often failed to be protective against
RSE. Thus, there is an urgent need for new anticonvulsants that can increase midazolam efficacy and reduce
benzodiazepine-resistant SE. Neurosteroids such as the ganaxolone (FDA-approved) have emerged as robust
anticonvulsants for nerve agents and RSE. Recently, novel hydrophilic analogs (“super-ganaxolones”) have been
identified as promising anticonvulsants that can surpass the limitations of ganaxolone, which lack water-solubility
and has limited absorption, half-life and dosing options. This project is designed to optimize new hydrophilic
synthetic analogs of the ganaxolone (super-ganaxolones) as anticonvulsants for nerve agent-indued RSE
and brain damage. This novel therapy is based on the proven efficacy of neurosteroids, targeting cellular changes
involved in OP neurotoxicity and RSE. The central hypothesize is that super-ganaxolones enhance phasic
and extrasynaptic tonic inhibition controls nerve agent-induced RSE and neuronal damage more effectively
than benzodiazepines and thereby optimally mitigate long-term dysfunction. The primary emphasis is to
optimize lead drugs with requisite biopharmaceutical traits, robust efficacy and acceptable safety profile and
advance one lead drug for further development under the FDA “Animal Rule” pathway. These pilot studies shows
that these drugs are formulated as dry powders for injection that offer an unprecedented shelf life of 10-years for
stockpiling as medical countermeasures. Studies are organized as four specific aims to deliver a lead drug: (Aim 1)
To synthesize and optimize novel hydrophilic neurosteroids that can effectively activate synaptic and extrasynaptic
GABA-AR-mediated tonic inhibition and elicit anticonvulsant effects with low risk of side effects. (Aim 2) To
determine the efficacy of top lead drugs against DFP-induced RSE and brain damage. (Aim 3) To confirm the
efficacy of a lead drug against Soman-induced RSE and brain damage. (Aim 4) To optimize PK and safety of a lead
drug and file IND application. The project will be implemented as per the “go/no-go” milestones plan. Test drugs
will be given by IM injection 40 min (in combination with midazolam) or 90 min (sequential) after OP exposures. The
key outcome measures of drug effectiveness include: (i) tonic inhibition potency; (ii) anticonvulsant efficacy, (iii) side
effects and off-target activity; (iv) neuroprotection; and (v) attenuation of neurological dysfunction, including sex
differences in efficacy and safety. Based on these pilot studies, test drugs are expected to be safe and efficacious
for FDA approval for clinical use. The overall project's impact is high in delivering one well-characterized lead drug
for advanced development for nerve agent exposure.

Public health relevance
Project Narrative Nerve agents are lethal chemical threat agents. Current anticonvulsant benzodiazepines are less optimal to protect the brain from seizures and refractory status epilepticus following nerve agent exposure. This project is designed to develop and optimize novel hydrophilic neurosteroids as more effective anticonvulsants than midazolam for protecting military and civilians during chemical nerve agent exposure.